Biostatistics Facility Core

BIOSTATISTICS FACILITY CORE: PROJECT SUMMARY/ABSTRACT
The Biostatistics Facility Core (BFC) is a critical, highly utilized core resource in the Southern California
Environmental Health Sciences Center (SCEHSC) which directly supports SCEHSC investigators’ research
projects and pilot projects through consultation about study design for human subjects and experimental
research, statistical methodology advice, and assistance with various statistical applications. Specifically, the
BFC: (1) reviews research proposals to assist in the development of appropriate study designs, conducts sample
size (power) calculations, and reviews proposed statistical methods; (2) provides advice on appropriate statistical
methods, assists in the implementation of statistical software, and helps investigators interpret results of
statistical analyses; (3) provides bioinformatics support for management and mining of data from genotyping,
gene expression, proteomic, epigenomic, metabolomic, and other large-scale technologies; (4) provides an
interface between investigators and statistical resources and provides user support for computer hardware and
software resources; (5) works in collaboration with the Exposure Factors Facility Core and Integrative Health
Sciences Facility Core to provide educational support and comprehensive study support for SCEHSC
investigators; and (6) works with the Community Engagement Core to translate environmental health sciences
research findings to media sources, community groups, and government agencies. As a result of these BFC
services, SCEHSC investigators receive priority access to critical cost-effective statistical services and support.
The unmatched qualifications and specialized experience of the BFC personnel and staff have been proven in
past grant cycles to deliver new methodologies, contribute to investigators’ study design and execution, provide
continuing education on current and changing research, and promote collaboration among SCEHSC
investigators and outside investigators in environmental health sciences research.